A Family Peer Navigator Model to Increase Access and Initial Engagement in Coordinated Specialty Care Programs Among Black Families

ABSTRACT
Family members have a key role in facilitating the initiation of mental health services. Yet, Black/African
American families often encounter barriers and experience delays accessing coordinated specialty care
programs. These delays can be attributed to individual (e.g., knowledge), interpersonal (e.g.,
connectedness), community (e.g., access), and societal (e.g., discrimination) factors. In other health related
areas, peer navigator models improve access to much needed services and promote more positive
experiences among individuals and their families. However, there are have been no family peer navigator
models developed to address the complexities that impact Black/African American families to improve access
to coordinated specialty care programs. Preliminary research suggests approximately 70% of Black/African
American family members report no contact with clinicians prior to initial diagnosis and the receipt of services
for early psychosis. Among Black/African Americans, family member engagement prior to services and during
treatment for first episode psychosis significantly impacts clinical and functional outcomes among youth
enrolled in coordinated specialty care programs. Building upon formative research, this mixed methods study
will be conducted in three phases to develop, refine, and pilot-test a multi-component Family Peer Navigator
model designed to increase access and engagement in coordinated specialty care programs Black families.
A community advisory board will provide feedback during each Phase II and III to refine the navigator model.
The Family Peer Navigator model will utilize telephone-based strategies and encompass the Cultural
Formulation Interview to tailor family psychoeducation and care coordination. Phase I and Phase II utilize an
exploratory-sequential mixed methods design to refine the Family Peer Navigator model and implementation
strategy. Phase I involves qualitative interviews with coordinated specialty care directors and providers, and
agency-level administrators. Phase II is a 4-month open trial that will recruit up to 10 Black families. Phase
III will consist of an embedded mixed methods designed randomized pilot trial of the Family Peer Navigator
model against a low-intensive care coordination in two coordinated specialty care programs. The
acceptability, feasibility, and preliminary impact will be assessed in a sample of 40 Black/African American
families with a loved one at risk for psychosis or currently experiencing their first episode of psychosis. Other
outcomes include proposed treatment targets (self-efficacy, knowledge, social connectedness), preliminary
impact outcomes (time to coordinated specialty care programs, initial family engagement), and
implementation outcomes (acceptability, feasibility, appropriateness). This study will establish an innovative
culturally informed family peer navigator model and generate preliminary data to support a Type II hybrid
effectiveness-implementation R01 application.

Public health relevance
PROJECT NARRATIVE The proposed study is highly relevant to public health because of its focus on reducing inequities in mental health service utilization among Black individuals and their families. This proposed study will develop a culturally informed Family Peer Navigator model for Black/African American youth and their families, and evaluate its acceptability, feasibility, and appropriateness in coordinated specialty care programs. With the goal of providing services early in the pathway to care for psychosis to increase access and initial engagement in coordinated specialty care programs.